Investigating facilitator-driven, multi-level implementation strategies in Federally Qualified Health Centers to improve provider recommendation and HPV vaccination rates among Latino/a adolescents

Project Summary/Abstract
Approximately 46,143 new cases of human papillomavirus (HPV) associated cancers occur annually in the U.S
and there are substantial racial, ethnic, socioeconomic, geographic and gender disparities in the incidence and
mortality of these cancers. Despite the availability of highly effective HPV vaccines that can reduce HPV-
associated cancer mortality, HPV vaccination rates in Texas rank 48th nationwide. Although evidence shows
Latino parents are more accepting of HPV vaccination than non-Hispanic parents, this disparity in vaccination
rates underscores the importance of understanding Latino parental HPV vaccine hesitancy. Latinos/as typically
receive healthcare at Federally Qualified Health Centers (FQHCs), which often need support implementing and
improving access to evidence based preventive services. However, the current literature around
implementation comes from large integrated healthcare systems and there is limited research around what
works in the FQHC settings with Latino/a patients. Implementation studies, with an equity focus, in these
resource-limited settings like FQHCs, are essential to make progress towards state and national HPV
vaccination targets. Preliminary data from our previous work suggest practice facilitation is a feasible approach
for building the capacity in FQHCs to select and implement provider- and practice-level strategies for
increasing vaccination rates. Using a stepped-wedge cluster randomized trial, we will randomize three FQHCs
(n=9 practices, 3 per FQHC) to receive facilitator-driven provider- (i.e., education, clinical practice plan) and
practice-level (i.e., technical assistance plus assessment and feedback, training, and education of
immunization navigators) implementation strategies. Informed by our conceptual framework and i-PARIHS, we
will measure effectiveness (i.e., HPV vaccination initiation and completion among adolescent patients) and
implementation outcomes (i.e., number of providers giving HPV vaccine recommendations and confidence
among parents in vaccinating their children). We will conduct a baseline assessment at each clinical practice,
which will provide comprehensive data to assist the practice facilitator in engaging with the providers and
leadership using a participatory approach to develop an implementation plan with strategies for each practice.
Along with quantitative evaluations, we will employ theory-guided, qualitative methods of inquiry, to assess the
complexity associated with context (including parental HPV vaccine hesitancy and provider confidence in
addressing it) and the recipients involved in the implementation of strategies in practices, along with
sustainability. The study will advance our understanding of what it means to conduct implementation research
in resource limited practices that work with populations experiencing substantial disparities. Findings from the
current study will inform national implementation efforts and contribute towards future research targeting
dissemination and scale-up, key foci for health equity focused implementation research.

Public health relevance
Project Narrative Latinos/as and other racial/ethnic minorities, rural residents, and economically vulnerable populations typically receive healthcare at Federally Qualified Health Centers (FQHCs), which often need support implementing and improving access to evidence-based preventive services. Aligned with the priorities of NOT-MD-22-006: Research to Address Vaccine Hesitancy, Uptake, and Implementation among Populations that Experience Health Disparities, this proposal considers the HPV vaccine as the evidence-based intervention and proposes a hybrid type III study that uses previously-piloted implementation strategies (i.e., practice facilitation, provider education, among others) to influence provider recommendations (implementation outcome) and ultimately practice-level vaccination rates (effectiveness outcome). To test whether these facilitator-driven implementation strategies influence our implementation and effectiveness outcomes, we will use a stepped- wedge cluster randomized trial and randomize three FQHCs (n=9 practices, 3 per FQHC) in Texas to three clusters.